World Reference Center for Emerging Viruses and Arboviruses (WRCEVA)

ABSTRACT
As underscored by pandemic COVID-19, Zika, yellow fever and chikungunya viruses, new and emerging
viruses represent increasing threats to human health, yet their mechanisms of emergence remain poorly
understood, and effective interventions are not available for most. Research on their pathogenesis, ecology,
evolution, epidemiology, emergence mechanisms, diagnostics, vaccines and therapeutics remain critical public
health needs. The World Reference Center for Emerging Viruses and Arboviruses (WRCEVA) comprises a
comprehensive, diverse collection of over 8,000 virus strains in 21 families, as well as antisera, antigens,
cDNA clones and other reagents to enable research worldwide. Approximately 400 new virus strains are added
annually, and 1000 viruses and reagents are shipped annually. The WRCEVA also maintains broad expertise
in both novel and traditional approaches to virus identification and characterization, and provides critical
support for emergency outbreak responses as exemplified by the rapid generation and distribution of critical
COVID and Zika reagents. This proposal seeks to continue these WRCEVA activities in support of NIH-funded
and other research on emerging viruses worldwide, through five Specific Aims:
1. Maintain a comprehensive set of emerging viruses, arboviruses and associated reagents to support
research and surveillance. The virus collection as well as antigens, antibodies, cDNA clones and other
reagents will be continually enhanced to capitalize on new emergence trends and technologies. Emphasis
during the first two years will be placed on the development of critical reagents for coronavirus research.
2. Discover, isolate and characterize newly acquired viruses to determine relationships and taxonomic
assignments, and to assess in vitro and in vivo host range. Clinical and field samples as well as viral
isolates will be received for identification and characterization, and added to the repository. Critical
phenotypes of newly discovered viruses and strains will be assessed by using in vitro and in vivo infections.
3. Perform sequencing and phylogenetic analyses of selected virus groups to determine evolutionary
histories and emergence mechanisms, patterns of spread/infection, and to rapidly determine the
sources of new outbreaks. Key virus strains will undergo genomic sequencing to generate databases that
can be exploited for the rapid determination of new outbreak sources, including potential bioterrorism.
4. Determine why yellow fever virus has not caused major urban epidemics in South America for many
decades, or ever in Asia. Our unique collection of virus strains and arbovirology expertise will be used to
examine hypotheses related to limitations on urban transmission by Aedes aegypti mosquitoes.
5. Train scientists in the identification and characterization of emerging viruses. To enhance research
and surveillance in the U.S. and worldwide, the most efficient way to limit spread of new outbreaks, training
in virus identification, characterization, and diagnostics will be provided to visiting scientists.

Public health relevance
PROJECT NARRATIVE Research on emerging viruses and arthropod-borne viruses requires diverse collections of virus strains as well as antibodies, antigens and other reagents that cannot be made at many scientific institutions. The World Reference Center for Emerging Viruses and Arboviruses (WRCEVA), established over 5 decades ago, maintains a comprehensive, diverse collection of over 8,000 virus strains in 21 families, as well as related reagents to enable emerging virus research worldwide.